CORE--Mouse

The purpose of this Core is to provide a central location for the supply of mice and services related to mouse care, maintenance, genotyping, and measurement. Specifically this Core will offer the following services: 1. Managing the mouse colony that includes the oversight of the generation, maintenance, and supply of single and compound genetically altered mice. 2. Perform bone marrow transplantation. 3. Measure arterial blood pressure in a standardized manner. 4. Prepare and implant Alzet pumps for the infusion of Angll or saline. 5. Harvest DNA by tail clipping for the purpose of genotyping. 6. In vivo ultrasound. Non-invasively quantify lumen diameter during the evolution of AAAs. Centralization of these facilities will permit an efficient use of resources for the Program, coupled with optimal quality control and standardization across Projects.